Development of outpatient antiviral cocktails against SARS-CoV-2 and other potential pandemic RNA viruses.

ABSTRACT: The overall platform and objective of the Stanford AViDD Center, “SyneRx,” is to develop
outpatient antiviral cocktails against SARS-CoV-2 and other potential pandemic RNA viruses. Thus, the goal of
each of our 7 Projects is to develop towards the clinic a novel direct-acting antiviral (DAA) with a distinct
mechanism of action, so that they can be used alone and in combination with other agents—providing additive,
and ideally synergistic antiviral activity. To maximize the achievement of this goal, we seek to create 3
scientific Cores that will each provide critical expertise and resources: the Structural Biology Core to offer
critical insights into our Projects’ antiviral targets and mechanisms of action; the Pandemic Assistance Core
to ensure adequate access to facilities with the requisite biosafety and containment to safely develop our
Projects’ antivirals against SARS-CoV-2 and other potential RNA pandemic viruses; and the Translation
Accelerator Core, in which is embedded the Industry Consultants Consortium, (ICC) to provide the requisite
translational resources, industry rigor and expertise to advance each project in a milestone and Go/no-Go
driven fashion. The range of planned activities spans the translational spectrum, from innovative target
discovery and lead identification, to lead optimization and IND-enabling activities. Our antiviral modalities
include small molecules, nucleic acids, and protein therapeutics. Our lead programs have demonstrated proof-
of-concept in vivo antiviral efficacy, with the potential to combat coronaviruses, as well as other RNA viruses of
pandemic potential. These efforts will include: a) targeting highly conserved RNA structures in viral RNA
genomes with locked nucleic acid (LNA) antisense oligonucleotide (ASO) and small molecule therapeutics; b)
improving formulations and delivery methods for nucleic acid therapeutics, and targeting virus-derived circular
RNAs; c) selectively targeting viral envelopes antiviral peptides and peptoids; d) developing small molecule
ligands of essential viral proteins that induce selective degradation of their protein targets; e) developing potent
and selective inhibitors of essential proteases of SARS-CoV-2 and other RNA viruses; f) developing small
molecule inhibitors of SARS-CoV-2 exonuclease to both promote lethal mutagenesis of the viral genome as
well as enhance the antiviral efficacy of ribonucleoside analogs; g) developing small molecule inhibitors of
SARS-CoV-2 NSP4’s role in membrane-associated RNA replication. We will establish an Administrative
Core to effectively manage and optimally support the above, and provide critical regulatory expertise. Finally,
we will leverage AViDD funding with institutional support, matching philanthropy and industry partnerships, and
strategic relationships to maximize preclinical development and ensure successful clinical and commercial
development of SyneRx’s most promising lead molecules. Successful accomplishment of our aims will yield
exciting synergistic outpatient antiviral cocktails for SARS-CoV-2 and other RNA viruses of pandemic potential.

Public health relevance
The overall platform and objective of the Stanford AViDD Center, “SyneRx,” is to develop outpatient antiviral cocktails against SARS-CoV-2 and other potential pandemic RNA viruses. Thus, the goal of each of our 7 Projects, which are supported by 3 scientific Cores—the Structural Biology Core, the Pandemic Assistance Core, and the Translation Accelerator Core—and an Administrative Core is to develop towards the clinic a novel direct-acting antiviral (DAA) with a distinct mechanism of action, so that they can be used alone and in combination with other agents—providing additive, and ideally synergistic antiviral activity.